MUCOSAL IMMUNITY AND HETEROLOGOUS PROTECTION INDUCED BY SINGLE-CYCLE SIV

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Phenotypic Differences in Homing Receptor Expression on SIV-specific CD8 positive T Cells Elicited by Intravenous versus Subcutaneous Inoculation with Single-Cycle SIV.